IN UTERO EXPOSURE TO 4T MR IMAGING IN FETAL GROWTH &TESTICULAR DVMT IN MOUSE

Confirm bioeffects observed at 4.7T. Increase RF and gradientlevels to higher level than used in 4.7T experiment. Investigatedevelopmental and hormonal changes in subject mice to obtain datafor NIH proposal.